Elucidating the Role of IL-1B Signaling in Shaping the Cardiac Immune Landscape After Injury

PROJECT SUMMARY
Cardiovascular diseases such as coronary artery disease, heart failure, and arrhythmia contribute
signiﬁcantly to morbidity and mortality worldwide. Cardiac inﬂammation plays a signiﬁcant role in disease
pathogenesis, and cytokines like the interleukin-1 (IL-1) family contribute signiﬁcantly to acute and chronic
inﬂammation. Therapeutic approaches that inhibit IL-1β signaling have been shown to improve cardiovascular
outcomes in patients with heart failure. However, the precise cellular targets of the IL-1 cytokine family in the
heart remain poorly deﬁned, limiting additional therapeutic development.
The heart contains two main populations of macrophages: CCR2- resident macrophages and CCR2+
monocyte-derived macrophages, the latter being a signiﬁcant source of IL-1β during cardiac injury. I have
generated preliminary data indicating that IL-1β signaling modulates immune cell behavior and differentiation.
The central hypothesis of this research is that IL-1 signaling to inﬁltrating monocytes and derived macrophages
promotes myocardial inﬂammation by driving their differentiation towards pro-inﬂammatory cell states, leading
to adverse cardiac remodeling.
Aim 1 seeks to deﬁne the impact of IL-1β signaling to inﬁltrating CCR2+ monocytes and derived
macrophages on cardiac remodeling and ﬁbrosis. Using transgenic Ccr2CreERT2IL1rf/fRosa26tdTomato mice, I will
conditionally knock out the IL-1 receptor in CCR2+ monocytes and macrophages and evaluate the effects on
myocardial inﬂammation, ﬁbrosis, and remodeling in two models of cardiac injury: pressure overload
(Angiotensin II/Phenylephrine infusion) and ischemia-reperfusion (IRI). This aim will clarify whether IL-1
signaling to CCR2+ macrophages is a viable therapeutic target to mitigate adverse remodeling.
Aim 2 investigates the mechanisms through which IL-1β signaling shapes the cardiac immune
landscape and immune cell differentiation. By leveraging genetic lineage tracing (Arg1tdT-CreRosa26ZsGreen) and
spatial transcriptomics, this aim will explore how IL-1 signaling inﬂuences the differentiation trajectories of
inﬁltrating monocytes and their progeny. Computational analyses will be used to examine the regional
organization and kinetics of immune cell differentiation during cardiac injury, with the goal of identifying
reparative and pathological immune niches within the heart.
Overall, this research will address critical gaps in understanding the contributions of IL-1 signaling in
cardiac inﬂammation and remodeling. Deﬁning how IL-1 signaling drives immune cell behavior and contributes
to adverse cardiac outcomes will provide key insights into the potential mechanisms underlying IL-1-targeted
therapies. Additionally, this work will help inform strategies to enhance the efﬁcacy and safety of these
therapies, with the ultimate goal of improving clinical outcomes for heart failure patients.

Public health relevance
PROJECT NARRATIVE Cardiovascular diseases like heart failure can signiﬁcantly impact quality of life and are driven by inﬂammation and adverse remodeling. Recent work indicates that the identities of cardiac macrophages, an immune cell population in the heart, may contribute to clinical outcomes after cardiac injury. The proposed research seeks to understand how a protein known as interleukin-1 beta affects cardiac macrophage identity, allowing us to better understand and improve therapies for heart failure that target interleukin-1 signaling.